Multiscale Stochastic Modeling To Meet the Needs Of Modern Microbial Biology

PROJECT SUMMARY
Cell proliferation is fundamental to life. Yet, proliferation is noisy at every scale. While molecular noise is
unavoidable, one might think that it gets averaged out and that proliferation becomes deterministic at the cell
and population scales. However, technologies like microfluidic culturing and DNA barcoding are revealing that
noise at the cellular and population scales is pronounced. For example, cell size fluctuations can last for many
generations, and microbial population sizes can fluctuate over many orders of magnitude. These striking and
fundamental statistical features are poorly understood, and new theoretical tools are needed to determine their
origins. Moreover, to disentangle whether noise is inherited from smaller scales or arises newly at each scale,
these tools must be multiscale. The goal of my group for the next five years is to develop predictive stochastic
descriptions of microbial proliferation that bridge the molecular, cellular, and population scales. Specifically, we
will develop stochastic descriptions that predict (i) the effects of molecular noise on microbial cell size control,
(ii) the effects of cell division noise on microbial population dynamics, and (iii) the statistics of microbial population
dynamics in fluctuating, clinically relevant environments. We will test these predictions against new data from
two experimental collaborators: one using microfluidic culturing to investigate cell size homeostasis in bacteria,
and one using DNA barcoding to investigate bacterial population dynamics in liquid culture and in realistic
environments such as tumors. To achieve this goal, I will draw upon my theoretical physics background, my
record of successful experimental collaborations, and my demonstrated expertise in multiscale stochastic
modeling. The outcome will be to transform my group into leaders in theoretical multiscale population biology.
This work will answer fundamental questions about microbial population dynamics and have important
implications for our understanding of the tumor microbiome and antibiotic resistance.

Public health relevance
PROJECT NARRATIVE Microbial proliferation is a fundamental but noisy process whose dynamics are still poorly understood at the cellular and population scales. The goal of this proposal is to develop stochastic theories of microbial proliferation that bridge the molecular, cellular, and population scales, and test the predictions against microfluidic culturing data and DNA barcoding data from two collaborating labs. This work will answer fundamental questions about microbial growth that will have important implications for our understanding of the tumor microbiome and antibiotic resistance.